Emergent role of allostery on function of GPCRs and Trimeric G proteins

Project Summary The structural biology revolution in G protein coupled receptors (GPCRs) over
the last two decades has pipelined a number of allosteric GPCR ligands into FDA clinical trials.
Over 500 GPCR-G protein complexes are now publicly accessible and represent only the ‘tip of
the iceberg’ of structures capturing ligand-GPCR-G protein complexes in biopharma. Despite this
information explosion, these structures only provide static snap shots that do not capture the
dynamic conformational landscape and allosteric communication that underlie the mechanism of
drug action. Further, the quest of understanding the G protein coupling selectivity by GPCRs has
necessitated enquiry into the role of sequence-divergent disordered structural regions of GPCRs
that are not resolved in high-resolution structures. To address these challenges, we have
developed innovative computational methods including AI centered techniques. Building on these
new technologies and conceptual advances from my lab, we propose the following parallel
research projects. (1) We have shown that the temporal coupling frequency of GPCR-G protein
interactions and allosteric communication modulate the G protein coupling selectivity by GPCRs.
Going forward we will dissect the structural basis of the allosteric modulation by the third
intracellular loop (ICL3). We will define roles for ICL3 in autoregulation and G protein selection in
closely related receptors. (2) Our extensive studies in identifying allosteric hotspot residues in
GPCRs involved in allosteric communication has yielded a procedure for locating cryptic binding
sites with allosteric communication propensity. Going forward we will exploit these findings to
develop a systematic workflow to identify allosteric modulator binding sites. To demonstrate the
use of the workflow we will also develop allosteric modulators for GPCRs. Our strong preliminary
data shows that this project will lead to a reliable workflow that can be used to identify allosteric
modulators for GPCRs. This workflow will also be broadly applicable to other proteins. (3) Our
studies on trimeric G proteins have shown that disease associated residue mutations allosteric to
the nucleotide binding site have a profound effect on the activation mechanism of G proteins.
Going forward we propose to dissect the similarities and differences in mechanism of Gβγ
dissociation from Gα subunit and the effect of mutations on this dissociation process.

Public health relevance
Project The protein-coupled GPCR heart activation class Narrative proposed research will advance our fundamental understanding of mechanisms of G receptor (GPCR) and trimeric G proteins. Insights gained from research into function can be used to identify new drugs with fewer side effects in diseases such as failure, neuropsychiatric disorders, and diabetes. Research into the molecular basis of of trimeric G proteins will pave way to identify allosteric drugs targeting G proteins, a of proteins for which there is no such drug to date.